Penn Center for AIDS Research: Feasibility and Acceptability of Extended-Release Buprenorphine and Peer Services Among Adults with HIV and OUD Exiting Jail

SUMMARY
Intersections among HIV, opioid use disorder, and incarceration are a national public health crisis requiring
innovative, multimodal intervention strategies that are responsive to geographically specific trends.
Philadelphia, Pennsylvania has been especially affected by this public health crisis. In 2021, Philadelphia
experienced a 9% increase in the number of people newly diagnosed with HIV and experienced its highest
number of deaths due to unintentional overdose, with 1,276 people dying that year, largely due to opioids
(82%). These trends, together with the ongoing HIV outbreak in Philadelphia among people who inject
drugs and the risk of overdose that is more than 37 times greater in the first two weeks of adults’
community return from Philadelphia jails than the risk in the general population, underscore the urgency of
the proposed research. In this research, we will develop a new integrated intervention to respond to this
HIV outbreak, improve HIV care engagement and outcomes, and reduce HIV and opioid use risk behaviors
among a highly vulnerable population: people with HIV and opioid use disorder who are preparing for
community return from the Philadelphia Department of Prisons. This study will draw upon the Consolidated
Framework for Implementation Research (CFIR) to pursue the following aims: 1) Assess feasibility,
acceptability, facilitators and barriers to providing XR-buprenorphine with 15 people living with HIV and
experiencing opioid use disorder who are preparing for community return from the Philadelphia Department
of Prisons; 2) With findings from Aim 1, develop a peer navigator intervention to be integrated with XR-
buprenorphine to reduce barriers and strengthen facilitators to accessing XR-buprenorphine, HIV case
management and treatment, and community-based substance use treatment; and 3) Assess feasibility,
acceptability, facilitators and barriers to providing integrated XR-buprenorphine and peer navigator services
with 15 people living with HIV and experiencing opioid use disorder who are preparing for community return
from the Philadelphia Department of Prisons. From the outset, this study carries immediate potential to
save lives. Achievement of its aims will advance scientific understanding and clinical implementation of an
innovative, integrative intervention to improve HIV and substance use outcomes for people exiting jail and
facing complex intersecting risks.

Public health relevance
RELEVANCE This study, which assesses the feasibility and acceptability of extended-release buprenorphine alone and then in combination with a peer navigation intervention among people experiencing HIV, opioid use disorder, and preparation for community return following incarceration, holds promise to improve post-incarceration linkage to HIV care, improve HIV and substance use outcomes, and reduce the high risk of fatal overdose following incarceration. In line with the funding priorities for this award, this study advances emerging science and enhances capacity in the treatment, response, prevention, and health equity pillars of the Philadelphia plan to end the HIV epidemic.